Discovering targets for neuroblastoma differentiation therapy from the human druggable genome

Discovering targets for neuroblastoma differentiation therapy from the human druggable genome
Abstract
Neuroblastoma (NBL), an aggressive childhood cancer, arises from differentiation-defective neural crest
precursor cells. Differentiation therapy, an approach to halt tumor growth by inducing differentiation of the
malignant cells, plays a critical role in treating NBL. There is a high demand for more effective differentiation
agents because > 50 % of the high-risk NBLs are resistant to currently available differentiation agents. However,
the mechanisms that block NBL cell differentiation have not been fully elucidated, which set an obstacle to
developing new differentiation agents. The objective of this study is to discover novel druggable differentiation-
blocking oncogenes from the human druggable genome and to preliminarily investigate inhibitors for protein
products of the identified key oncogenes as differentiation agents in NBL cells. The hypothesis is that novel
druggable oncogenes which function as blockers of NBL cell differentiation can be discovered via a siRNA-based
high-content screening (HCS) of the druggable genome and that inhibitors for protein products of the identified
genes are potential candidates for differentiation therapy. The hypothesis is strongly supported by a pilot HCS of
siRNAs against 352 druggable genes in a NBL cell line BE(2)-C, which identified 6 differentiation-blocking
oncogenes. Three of the 6 genes are novel discoveries, whereas the remaining 3 genes are previously identified
oncogenes in NBL and FDA-approved inhibitors for their protein products have been shown to have
differentiation-inducing activities. Four Specific Aims are proposed: Aim 1, systematically investigate the
druggable genome and identify differentiation-blocking oncogenes. This will be done by (1) performing HCS of
a library of siRNAs against the human druggable genome and identify genes with their knockdown inducing
neurite-outgrowth and cell growth arrest, the differentiation marker of NBL cells, in BE(2)-C, and then (2)
validating the identified genes using additional siRNAs and by measuring NBL molecular differentiation markers.
Aim 2, discover novel differentiation-blocking oncogenes and novel differentiation-regulating pathways by
informatics analysis of the identified genes. Aim 3, investigate the generic differentiation-blocking functions of
the key novel genes in a panel of NBL cell lines with different genetic backgrounds. Six novel genes will be
investigated in this grant period, which will be selected based on the potency ranking from HCS. Aim 4,
investigate the differentiation-inducing activities of protein inhibitors for the identified key novel genes in NBL cell
lines. Six novel genes will be investigated in this grant period, which will be selected based on the potency
ranking from HCS, genericity shown in multiple cell lines and availability of FDA-approved inhibitors for their
protein products. The study is innovative because the proposed HCS approach has not been used to investigate
the entire druggable genome for NBL cell differentiation. The study is significant because success of this study
will not only advance our understanding of the mechanisms that control NBL cell differentiation but will also
directly provide a group of novel druggable targets for developing new differentiation agents.

Public health relevance
Project Narrative The goals of this project are to identify novel druggable differentiation-blocking oncogenes from the human druggable genome in neuroblastoma cells and to investigate the available FDA-approved inhibitors for protein products of the identified genes as novel differentiation therapeutic agents. The proposed research is relevant to public health because successful application of the identified FDA-approved inhibitors to neuroblastoma therapy would result in survival benefit for neuroblastoma patients. Thus, the proposed investigation is consistent with the NCI mission of fighting cancer and is relevant to the NIH mission to acquire and apply knowledge to reduce the burden of illness and disability.